A Novel Postoperative Prognostic Liquid Biopsy: Tumor-Associated cfDNA and Leukocyte Analysis in Oropharyngeal Cancer Surgical Drain Fluid

PROJECT SUMMARY/ABSTRACT
The incidence of oropharyngeal squamous cell carcinoma (OPC) driven by high-risk (HR) HPV strains
continues to rise. As HPV (+) disease is prognostic for good post-treatment outcomes and arises in relatively
young patients with fewer co-morbidities, clinicians now recognize it as a distinct clinical entity from tobacco-
associated HPV (-) disease. But despite improved survival following surgery and adjuvant chemoradiation
(CRT), many HPV (+) OPC patients suffer prolonged morbidity from severe treatment-associated toxicities.
This has led to many treatment de-intensification clinical trials, which seek to reduce toxic side effects while
maintaining historic survival rates. Ideally, high-risk patients would remain on standard regimens while low to
intermediate-risk patients would receive de-escalated therapy. However, there is a great clinical need for an
objective biomarker of risk to aid the subjective clinical assessments: pre-treatment imaging and postoperative
pathology. Liquid biopsies can offer such objectivity; they quantify cell-free DNA (cfDNA) shed by cancer cells,
called circulating tumor DNA (ctDNA), in biofluids like saliva or plasma. Further, in HPV (+) OPC, cell-free HPV
DNA (cf-HPV) parallels ctDNA as a measure of minimal residual disease (MRD). But plasma and saliva assays
lack sensitivity to detect this cf-HPV MRD after surgery. To this clinical challenge, we offer our novel liquid
biopsy assay of Jackson Pratt (JP) surgical drain fluid (SDF). We believe SDF will be enriched with cf-HPV
compared to plasma because it's more proximal to the primary tumor resection site and to the lymph nodes,
where locoregional micrometastases are seeded. Additionally, because the JP drains also capture lymph fluid
from the lacerated cervical lymphatic system, we also believe the SDF contains informative effector leukocytes
that were in transit to the tumor microenvironments (TMEs) of metastatic nodes and the primary tumor. To
begin to elucidate the prognostic potential of SDF, we have collected paired SDF, plasma, tumor biopsy, and
metastatic lymph node samples. First, using PCR and next-generation sequencing approaches we will quantify
the cf-HPV burden in paired plasma and SDF samples. Then we will compare cf-HPV in each sample type
individually to histopathological markers of risk (extranodal extension and tumor stage) and recurrences. We
will then track tumor-informed variants on ctDNA, isolated from plasma and SDF, to show that ctDNA levels
align with cf-HPV and further validate that cf-HPV is a good proxy for MRD. Lastly, we will use digital cytometry
tools and mass cytometry to immunophenotype the immune cells within the SDF to determine if they reflect
immune response gene expression levels in paired metastatic nodes and tumors. If confirmed, our study has
the potential to demonstrate that tri-biomarker analysis (immune cell, cf-HPV, and ctDNA) in a novel liquid
analyte (SDF) can provide precision risk-stratification to aid subjective clinical diagnostics.

Public health relevance
PROJECT NARRATIVE Subjective clinical assessments of patient risk in HPV-associated oropharyngeal squamous cell carcinoma (OPC) could be improved with our novel objective liquid biopsy assay of the inflammatory fluid that collects in Jackson Pratt surgical drains. We believe we can use this proximal liquid analyte to sensitively detect tumor-shed cell-free HPV (cf-HPV) and comprehensively characterize tumor homing effector immune cells. We predict the integration of surgical drain fluid cf-HPV analysis with leukocyte immunophenotyping will predict patient pathological risk and patterns of recurrence, and could eventually be used to prospectively select candidates for treatment de-intensification clinical trials.